Efficient Brain Delivery of Neuroprotective TrkB Agonist Antibodies in Alzheimer’s Disease Using CD98hc Bispecific Shuttles

Alzheimer’s disease (AD) is the most common age-related neurodegenerative disease. Despite the great
potential of biologics (e.g., therapeutic antibodies) to affect AD pathophysiology, these agents are generally
unable to penetrate the blood-brain barrier (BBB), which represents their biggest hurdle to clinical efficacy. One
promising strategy is to use bispecific antibody BBB shuttles, which involve fusing IgGs to a second affinity ligand
that engages a cerebrovascular endothelial target and induces transport across the BBB. While most previous
work has focused on BBB shuttles that target transferrin receptor (TfR-1), my lab has developed a BBB shuttle
that engages CD98hc, the heavy chain of the large neutral amino acid transporter (LAT-1). Notably, our
preliminary data demonstrate superior brain parenchymal delivery and retention of IgGs shuttled via CD98hc as
compared to those shuttled via TfR-1. Importantly, this first-generation CD98hc shuttle enables brain delivery of
off-the-shelf IgGs simply by attaching a single-chain CD98hc antibody to the C-terminus of one of the two IgG
heavy chains. The objectives of this proposal are twofold: i) to define the optimal CD98hc shuttle characteristics
(CD98hc single-chain affinity, valency, and epitope) for maximal brain parenchymal delivery and retention to
guide the design of second-generation CD98hc shuttles; and ii) to generate proof-of-concept efficacy data in an
AD mouse model (tau, PS19) using a TrkB agonist antibody that induces neuroprotective signaling. For the first
objective, I hypothesize that BBB shuttles with monovalent CD98hc single-chain antibodies (as used in the first-
generation shuttle) and reduced CD98hc single-chain antibody affinity (relative to the first-generation shuttle) will
maximize antibody concentrations in the brain parenchyma by improving antibody dissociation at the abluminal
side of the brain endothelium, as observed for TfR-1 shuttles. For the second objective, I hypothesize that
CD98hc shuttles that deliver TrkB agonist IgGs to the brain parenchyma of tau transgenic mice will reduce
neuronal and synaptic loss and cognitive deficits. This hypothesis is supported by the partial efficacy of non-
shuttled TrkB antibodies delivered systemically and high efficacy of viral brain delivery of the TrkB ligand in AD
mouse models. Therefore, I propose in Aim 1 to develop an optimized second-generation CD98hc shuttle by
evaluating the impact of CD98hc single-chain antibody affinity, valency, and epitope on antibody concentrations
in the mouse brain parenchyma as a function of time. Next, in Aim 2, I propose to evaluate the ability of a first-
generation CD98hc shuttle to deliver a TrkB agonist IgG to the brain parenchyma, to activate TrkB in wild-type
and tau (PS19) transgenic mice, and to mediate neuroprotection in tau transgenic mice. A key expected outcome
is the development of an optimized CD98hc shuttle that can be used to deliver a wide range of existing
therapeutic antibodies to the brain parenchyma. A second key expected outcome is preclinical data for TrkB
agonism in AD mouse models. These findings are expected to enable future studies of single and combination
therapies using antagonist and agonist antibodies that target mechanistically unique pathways.

Public health relevance
The goal of this research is to improve the delivery of therapeutic antibodies to the brain by generating bifunctional antibodies that target both a protein at the blood brain barrier and a target within the brain. This research will involve optimizing bifunctional antibodies to achieve high and sustained antibody levels in the brain, and then using them to prevent Alzheimer’s disease-like pathology in animal models. The bifunctional antibodies and insights gained in this work are expected to accelerate the development of therapeutics for treating Alzheimer’s disease and other neurodegenerative disorders.